Endowment for Cardiometabolic Health Disparities Research

Project Abstract
The long-term objective of the Endowment for Cardiometabolic Health Disparities Research is to expand the
capacity of Meharry Medical College (MMC) to enhance research and research training in minority health. The
program will address health disparities in cardiometabolic health disproportionately prevalent in the African
Americans in Nashville and Davidson County, the catchment areas of MMC. We will accomplish this objective
by recruiting a well-established anchor faculty to build intellectual capacity, increasing the number of PhD
students from underrepresented backgrounds in health disparity research, providing interdisciplinary research
and leadership training to postdoctoral fellows and junior faculty from underrepresented backgrounds, and
increasing the number of health professional faculty involved in cardiovascular health disparity research. To
achieve our goal, there are 5 priority activities. Priority Activity 1 is to develop a bachelors to masters to PhD
pathway program in partnership with nearby undergraduate HBCU institutions. We will develop graduate
curriculum and establish a new PhD training graduate concentration in cardiometabolic health disparities
research. Priority Activity 2 is to hire a Senior Magnet Cardiovascular Scientist and Junior Scientist to build a
corpus of researchers. Priority Activity 3 is to develop a research leadership program for postdoctoral fellows to
early-stage tenure-track faculty underrepresented in medicine and science to allow them to successfully
establish their independent research programs and transition to successful tenure status. Priority Activity 4 is to
establish an annual Presidents Seminar to bring accomplished, nationally recognized prominent researchers on
the Meharry campus to present and to engage with our PhD candidates and faculty for new networking/mentoring
opportunities. Priority Activity 5 is to invest in research infrastructure to advance technological innovation on our
campus for experimentation, data collection, and translational research focused on health disparities of
cardiometabolic disease. With endowment funds secured through the S21 mechanism, we will provide robust
training opportunities to encourage more participation in health disparities research focused on cardiometabolic
diseases. The impact will be establishment of a sustainable program that includes health disparity curricula for
graduate students, a postdoctoral fellow to tenure-track faculty development pathway, and a critical corpus of
health disparity researchers with active research projects in the area focused on cardiometabolic health
disparities. Leveraging our ongoing academic relationships with the neighboring undergraduate HBCUs, training
pathways in partnership with Tennessee State University and Fisk University, located in the one-mile corridor of
MMC, will create a scholarly environment for teaching and research to address the challenge of halting and
reducing the widening gap of cardiovascular health disparities within the minority populations of the US.

Public health relevance
Project Narrative The long-term objective of the Endowment for Cardiometabolic Health Disparities Research is to expand the capacity of Meharry Medical College (MMC) to enhance research and research training in minority health. The program will address health disparities in cardiometabolic health disproportionately prevalent in the African Americans in Nashville and Davidson County, the catchment areas of MMC. This will be accomplished by recruiting and developing new research faculty, establishing a new PhD program in cardiometabolic health disparities, and promoting research infrastructure.